Chemical Approaches to Control the Function of Regulatory RNAs

Recent decades have dramatically changed our view of RNA. While RNA was initially believed to be barely
a passive messenger in the transfer of genetic information from DNA to proteins, it is now clear that RNA is
an exciting and underexplored regulatory molecule that will continue to deliver new discoveries in biology
and medicine. Our research program strives to capitalize on these exciting future discoveries by exploring
chemical modifications to modulate the structure and function regulatory RNAs. The long-term goals are to
1) develop novel RNA chemical modifications for fundamental studies and biomedical applications, and 2)
explore new modes of sequence-specific recognition of double-stranded RNA (dsRNA). Our research
program comprises two distinct but interrelated projects: 1) novel backbone modifications to improve
specificity of regulatory RNAs, and 2) triplex-forming peptide nucleic acids (PNAs) to modulate structure and
biological activity regulatory RNAs. Project 1 replaces internucleotide phosphates with amides and other
non-native linkages in short interfering RNAs and RNAs associated with clustered regularly interspaced
short palindromic repeats (CRISPR). The goals are to optimize the activity and sequence specificity of these
RNAs. The premise is that backbone modifications will remodel and improve RNA-protein interactions and,
hence, modulate the activity and specificity. Project 2 explores chemically modified PNA as a ligand for
sequence-specific conformational and functional control of biomedically important dsRNA. The goals are to
develop PNAs that shift between alternative structures of complex RNAs and to improve the cellular uptake
of PNA. The premise is that nucleobase-modified triplex-forming PNAs are uniquely suited for sequence-
specific recognition of dsRNA and will enable recognition of biologically important non-coding dsRNA. New
future directions will focus on biological activity of PNAs, especially, in phase-separated membrane-less
organelles. The projects involve collaborations with structural biochemists (Martin Egli, Janez Plavec),
biological chemists (Naoki Sugimoto), and biotech companies (Korro Bio, Inc.). The two projects share a
common theme of designing chemical modifications that take advantage of charge complementarity
between the RNA target and the ligands and proteins interacting with RNA. The overreaching idea is to
develop RNA chemical modifications and RNA binding ligands that avoid unproductive electrostatic
repulsion and capitalize on productive electrostatic attraction while concurrently enhancing sequence
specificity of molecular interactions. This thrust grows out of our recent discoveries that RNA is unusually
receptive to chemical modifications that neutralize the negative charge of phosphate backbone, both in RNA
itself and in RNA binding oligonucleotide analogues. If successful, our research will contribute to addressing
key gaps in RNA interference, CRISPR, and PNA technologies for recognition of therapeutically relevant
RNAs, and will open doors for development of unique research tools and new therapeutic strategies.

Public health relevance
Double stranded RNAs are exciting regulatory molecules, powerful tools for basic biological sciences, and targets for novel therapeutic approaches. This proposal will explore chemical modifications to optimize the properties of such RNA molecules and study the mechanism of their action. If successful, the project will create improved research tools, provide unique insights into structure and function of RNA and may open doors for development of new drugs for diseases where the traditional pharmaceutics have been less successful.